Advancing Medical Imaging Software with Machine Learning for NIH-Supported Research

Project Summary/Abstract
The goal of this application is to support Alan Morris, MS, as a Research Software Engineer at
the Scientific Computing and Imaging Institute at the University of Utah. He works primarily on
research software supported by NIH grants under the direction of Drs. Shireen Elhabian and
Andrew Anderson. The primary focus of his work is the development of software for medical
image and shape analysis and in supporting the research of the faculty and students at the SCI
Institute. This Research Specialist Award would allow 3 years of funding to maintain protected
time for Mr. Morris to work on supporting NIH-related research software projects with the
particular focus of enhancing them with robust machine learning support and infrastructure. The
results of this work will be disseminated through open-source software releases, peer-reviewed
journal manuscripts, and presentations at local and national meetings.

Public health relevance
Project Narrative Alan Morris, MS, supports the Scientific Computing and Imaging Institute at the University of Utah. His work has made significant contributions to the development of research software for medical image and shape analysis. Support from this award will allow him to focus his effort on enhancing research software with robust machine learning support and infrastructure, enabling researchers and students at the SCI Institute to conduct cutting-edge research in medical image analysis.